COMPARISON OF IMP &HMPAO CEREBRAL SPECT IN ALZHEIMERS

This study will compare the utility of two single photon emission computed tomography (SPECT) radiopharmaceuticals - N-isopropyl-p-123l- iodoamphetamine (IMP) and 99mTc-hexamethylpropyleneamine oxime (HMPAO) - in detecting cerebral perfusion deficits in mild Alzheimer's Disease (AD). The knowledge thus derived will represent a substantial contribution to the field. For while numerous investigators have found perfusion deficits in AD using individual pharmaceutical agents, almost no work has been devoted to the selection of a superior agent for this purpose. As the diagnostic usefulness of SPECT in AD will ultimately depend on its ability to detect subtle lesions early in the course of illness, a comparative tracer study is not only timely, but essential. Subjects for the study will include 20 patients with mild AD and 10 healthy matched controls. Following a careful diagnostic evaluation and neuropsychological testing, each subject will undergo two cerebral SPECT scans - with IMP and HMPAO - within a 30 day period in a counter-balanced order. Scans will be performed with a recently designed SPECT system which has multi-slice whole brain imaging capabilities. Transverse slice images will be reconstructed, and cortical and cerebellar regions of interest (ROI) will then be defined. Regional indices of tracer distribution will be computed by dividing mean count rate per pixel for cortical ROIs by that of cerebellar ROIs. An analysis of variance and a discriminant analysis will be performed in order to determine which combination of radiopharmaceutical and ROI maximally discriminates Alzheimer's patients from normals.